Examining Neighborhood Profiles Defined by Place-Based Community Features and their Relationships with Firearm Violence Disparities

PROJECT ABSTRACT
Black Americans are over six times more likely to experience an assault-related firearm injury compared to
White Americans. Thus, while a White American is admitted to the hospital due to firearm assault every 2 days,
a Black American is admitted every 9 hours. Residential segregation, vacant and abandoned properties,
neighborhood walkability, and green space access represent key place-based community features of the urban
environment that contribute to Black Americans’ elevated gun violence exposure. However, existing research
has relied on regression-based statistical techniques focused on the independent, variable-centered
relationships that these features share with firearm violence. There is a critical need for a comprehensive
examination of the joint effects of these place-based features that utilizes a place-centered technique. Such a
technique will reveal how these place-based community features interact to create neighborhood profiles that
position Black Americans for gun violence exposure. The proposed project will utilize latent profile analysis – a
place-centered, latent variable classification technique – to fill this knowledge gap using existing data on the N
= 1644 populated census blocks from the City of Syracuse, NY. Data will be obtained from several sources
including the US Decennial Census (residential segregation, neighborhood walkability), the City of Syracuse
(vacant and abandoned properties, green space access), the Central New York Crime Analysis Center (firearm
fatalities), and the State University of New York Upstate Medical Center (non-fatal firearm injuries). These data
will be linked at the census block level to complete the following aims: 1) To assess how residential
segregation, vacant and abandoned properties, neighborhood walkability, and green space access combine to
form distinct neighborhood profiles; 2) To determine how different neighborhood profiles characterized by
unique combinations of these place-based community features display different levels of firearm violence
(firearm fatalities and non-fatal firearm injuries). Collectively, these aims will advance our overall objective to
further precision public health efforts that more effectively reduce Black Americans’ firearm violence exposure.
This will be achieved by informing policy and prevention strategies that are tailored to the pattern of place-
based features defining those neighborhoods that confer the greatest gun violence exposure risk. The project’s
focus on the influences of the sociocultural and physical environment on Black Americans’ firearm violence
exposure embeds it within NIMHD’s research framework and directly addresses NIMHD’s interest in
understanding the antecedents of violence in health disparity populations (NOT-MD-18-006).

Public health relevance
PROJECT NARRATIVE Black Americans are disproportionately impacted by firearm violence. The goal of the proposed project is to determine how residential segregation, vacant and abandoned properties, neighborhood walkability, and green space access combine in unique ways to create neighborhood profiles that differentially expose Black Americans to gun violence. This effort will inform policy and prevention strategies that more effectively reduce Black Americans’ firearm violence exposure by targeting the unique patterns of place-based features defining those neighborhoods conferring the greatest exposure risk.